Molecular Biophysics Training Program at Northwestern University

Project Summary
The core mission of the Molecular Biophysics Training Program (MBTP) at Northwestern University (NU) is to
train the next generation of pre-doctoral students in the highly interdisciplinary field of molecular biophysics.
This field seeks to describe and explain biological phenomena using fundamental physical, chemical, and
mathematical principles and to leverage this knowledge to develop new medicinal therapies and engineer new
biomedical tools and applications. As the sole training program at NU dedicated to this area, for 30 years
MBTP has played a key role in strengthening intellectual ties and stimulating interdisciplinary collaborations
among program preceptors, catalyzed by student trainees, spread over seven departments in the schools of
arts & sciences, medicine, and engineering.
Six pre-doctoral student trainees in their second and third years of graduate education from seven feeder
graduate programs will be recruited to and supported by the training program for a maximum of two years,
allowing the program to have the greatest impact early in their careers as trainees complete the required
coursework, learn to think critically, frame research questions independently, acquire and hone the requisite
technical skills to answer these questions, and develop operational skills to be effective communicators and
researchers. Trainee learning will occur through the completion of a core biophysics curriculum established by
the program that will allow students from diverse backgrounds to share a common didactic experience.
Trainees will have numerous opportunities to develop and hone oral presentation skills at program-sponsored
forums from intimate settings like journal clubs and research-in-progress meetings held every month to larger
audiences at monthly intramural seminars and the annual symposium. Monthly seminars, annual symposia
and career development forums featuring external speakers, who are also leaders in academia, industry, and
other non-academic careers will not only provide trainees with opportunities for broadening and deepening
knowledge in the field but also for networking and career advancement. MBTP is deeply committed towards
the development of all students including those from underrepresented backgrounds for broad impact.
The overarching goal of MBTP is to prepare pre-doctoral students of exceptional promise in the early
stages of their scientific careers to conduct rigorous, reproducible, and responsible research in molecular
biophysics by facilitating the development of both general competencies as well as the uniquely molecular
biophysical skills of deep analytical and quantitative reasoning and expertise in the application of cutting-edge
technologies to solve complex biological problems. By achieving our overarching goal, we will set students on
a trajectory towards independence in thought and action with skills that are compatible with a spectrum of
productive, intellectually-demanding careers in academia, industry, and beyond.

Public health relevance
Project Narrative The overarching goal of this proposal is to train pre-doctoral graduate students of exceptional promise for scientific research careers in molecular biophysics, which is an area that embraces principles and concepts from diverse fields in the natural sciences including biology, physics, chemistry, and mathematics. A rigorous quantitative foundation in molecular biophysics is vital for developing a deep understanding of the biology underlying a broad swath of public health issues, as this knowledge is key not only to the development of effective therapeutic strategies for mitigating diseases but also for the development of new biological tools and technologies. The training program envisioned in this proposal will thus address an urgent and critical need for highly-qualified research personnel in an area of vital importance to public health while ensuring the country's preeminence in biomedical research.